Microglial modulation of neurocircuits in HIV/cocaine comorbidity

Project Summary:
Despite the success of combination antiretroviral therapy (cART), a significant proportion of infected individuals
exhibiting neurocognitive decline, and a prior history of substance use disorder (SUD) may result in an
exacerbated rate of decline. Thus, prior drug history may be clinically significant in the treatment of
neurological HIV-1 infection. The specific aims of the project are: 1) To define the dendritic “spine-
targeted” - microglial interactions which produce HIV-1/psychostimulant-induced synaptodendritic
loss and spine dysmorphology. Dendritic spine loss is a key pathology of HAND; however, the underlying
mechanisms remain largely uncharacterized. We will investigate whether HIV-infected microglia play a key role
in spine loss/dysmorphology using an in vitro HIV infection model and psychostimulant drug exposures in sex-
specified brain cell cultures. 2) To establish whether a history of psychostimulant abuse drives an
accelerated progression of microglial dysfunction and dendritic spine alterations following HIV
infection. Dopamine will be assessed both prior to and after EcoHIV-infection in animals with or without a
history of cocaine self-administration. The mechanisms by which HIV-infected microglia produce dopaminergic
circuit dysfunction will be critically tested using proviral gene excision techniques; cART, and SABV are integral
factors of the design. 3) To establish executive function “choice” deficits in EcoHIV-infected animals,
and the role of microglial HIV infection, following psychostimulant self-administration. We will establish
prior drug history and HIV-1 infection as variables that influence the effect of fronto-striatal circuit dysregulation
on choice behavior, thereby identifying factors that may exacerbate resistance to treatment. We will examine
synaptodendritic integrity in pyramidal neurons of the medial prefrontal cortex (mPFC) and medium spiny
neurons (MSN) of the nucleus accumbens given their sensitivity to drug history and/or HIV-1 infection.
Targeted proviral gene excision of HIV from microglial cells will be used to determine the role of infected
microglial cells in executive function deficits. Thus, this proposal addresses two key questions regarding
neuroHIV – 1) does a history of drug dependence alter the progression and clinical outcomes of HIV-1-
associated neurocognitive disorders? and 2) how do substances of abuse and HIV interact to produce dendritic
spine alterations, one of the key neuropathologies of neuroHIV in the current cART era? The program goal is
to identify how microglial HIV infections produce synaptodendritic loss; knowledge that will lead to novel
therapeutic strategies for restoring fronto-striatal circuitry.

Public health relevance
Project Narrative: Despite the success of combination antiretroviral therapy (cART), HIV-1-associated neurocognitive disorders (HAND) continue to afflict patients on cART, with a significant proportion exhibiting neurocognitive decline. A history of substance use disorder (SUD) may alter the progression and exacerbate HIV-1 neurocognitive decline. We will critically test how a history of SUD alters the neurocognitive and neuropathological sequelae of HIV-1 infection. The basis of our approach is to identify how infection of microglial cells leads to alterations in the fronto-striatal circuitry following SUD and HIV-1 infection, focusing on mechanisms of dendritic spine loss - a key neuropathology of neuroHIV in the current cART era.